Tissue-based biomarkers of anti-PD-1-based therapy in metastatic renal cell carcinoma

PROJECT SUMMARY
Immunotherapy, particularly immune checkpoint inhibitors (ICI), has shown considerable success in the
treatment of advanced renal cell carcinoma (RCC), leading to durable responses in a subset of patients.
However, most patients do not derive long-term clinical benefit from existing immune therapies. Moving
forward, our team has prioritized identifying the determinants of ICI response in RCC, including the antigenic
targets, T cell phenotypes, and microenvironment features that ultimately dictate the effectiveness of tumor-
specific immunity.
Human endogenous retroviruses (ERVs) are often aberrantly expressed in numerous disease states,
including malignancy, and can lead to activation of both innate immunity (through sensing by the RIG-I/MDA-5
and cGAS-STING pathways) and adaptive immunity (by providing antigenic targets for tumor-specific CD8+ T
cells). The expression of ERVE-4 has been associated with response to ICI monotherapy (i.e. anti-PD-1) in an
analysis of a phase III randomized controlled trial in RCC, and an ERV-derived peptide (from ERVE-4) was
identified as a target epitope in a long-term RCC responder to allogeneic stem cell transplant. Beyond
recognition of tumor antigens, effective anti-tumor immunity requires a tumor microenvironment that permits
infiltrating CD8+ T cells to carry out their effector function. A high level of tumor infiltration by antigen-
experienced, non-exhausted CD8+ T cells has been associated with improved response to ICI monotherapy in
clinical trials of RCC. However, resistance to ICI monotherapy is still common, in part owing to the
immunosuppressive effects of infiltrating Treg and myeloid cells, and consequently combination (and not single
agent) therapies with PD-1 blockade as a backbone are now the standard-of-care treatment for advanced RCC.
It is therefore critical to understand the role of ERV expression, T cell phenotype, and the immune
microenvironment in the context of clinically relevant contemporary ICI-based combination therapies.
We hypothesize that aberrant expression of ERVs is associated with improved response to ICI
combination therapy with ipilimumab and nivolumab, and that characterization of T cell phenotypes and the
composition and states of other infiltrating immune cells in the RCC microenvironment will improve our
understanding of the determinants of ICI response. By leveraging our unique access to clinically relevant large-
scale clinical trial specimens of single-agent ICI and ICI-based combination therapy in RCC, as well as our
collaborative team of physicians, translational researchers, and experimental biologists, we aim to systemically
assess the association of ERV expression and ICI response and to determine other immune microenvironment
features that ultimately influence response to current RCC immunotherapies. Our multidisciplinary team brings
together a collective expertise in RCC biology, pathology, and tumor immunoregulation who are dedicated to
bringing meaningful results that will optimize clinical outcomes for patients with RCC.

Public health relevance
PROJECT NARRATIVE In 2015, then-President Barack Obama launched the Precision Medicine Initiative, which dictated a patient- powered emerging approach to disease prevention and treatment that takes into account individual differences in people's genes, environment, and lifestyles – making possible more effective, targeted treatments for diseases. In personalized medicine, biomarkers serve as indicators of disease prognosis and can potentially predict a patient's response to drug treatment, thereby informing clinical decisions and aiding risk stratification. Currently, there are no established biomarkers to guide treatment of metastatic renal cell carcinoma, a disease with many drugs with distinct mechanisms of action approved for first-line use. The establishment of robust biomarkers that can reliably identify which patients will benefit from immune checkpoint inhibitor therapies in the first-line setting would bring us closer to the overarching target of the Precision Medicine Initiative, and also reduce toxicities, lower treatment costs, and improve health-related quality of life in patients diagnosed with metastatic renal cell carcinoma.